TESTING ZAFIRLUKAST (ACCOLATE) IN SUBJECTS WITH ASTHMA EXACERBATIONS

Zafirlukast proven to be clinically safe and effective in the treatment of mild to moderate asthma. Patients having asthma exacerbations with FEV1 (spirometry <=70%) upon arrival in ED between ages 18-65 will receive B2-agonist, oral Prednisone, and either oral Zafirlukast 20 mg, 160 mg, or placebo administered in a predetermined randomized manner 30 minutes after baseline evaluation is completed and continued emergency therapy. Patients discharged home receive oral steroid, inhaled B2-agonists, asthma medications and either Zafirlukast 20 mg orally 2x/dayorplacebo (28 days).